Elucidating the functional role of KLRG1+ conventional helper T cells in the tumor microenvironment

PROJECT SUMMARY/ABSTRACT
The overall goal of this project is to define the functional role of killer cell lectin-like receptor G1 (KLRG1)
expressing tumor-infiltrating CD4+ FoxP3- T conventional helper cells (Tconv) in cancer and to develop a novel
immunotherapy to selectively deplete KLRG1-expressing CD4+ T cells for immunotherapy. Most clinically
relevant immunotherapies aim to augment or de-repress CD8+ T cell cytotoxicity, despite the central role of CD4+
T cells in shaping antitumor immunity by altering the balance of inflammation and immunosuppression in the
tumor microenvironment (TME). We have shown that KLRG1-expressing CD4+ T cell subsets, both Tconv and
regulatory T cells (Tregs), are highly correlated with the rate of immune escape in murine and human tumors.
Furthermore, these subsets are greatly reduced in tumors responding to immune checkpoint blockade (ICB),
suggesting that KLRG1-expressing CD4+ T cells may be biomarkers of ICB response. In preliminary
experiments, KLRG1+ Tconv cells express a highly distinct cytokine profile from their KLRG1- Tconv counterparts
that closely resembles that of tumor Tregs. Additionally, initial experiments demonstrate that KLRG1+ Tconv cells
are functionally immunosuppressive ex vivo, suggesting that this is a novel immunosuppressive cell type in the
TME. KLRG1 is a co-inhibitory receptor that has a canonical negative regulatory role on NK cells and cytotoxic
CD8+ T cells. However, the role of KLRG1 on CD4+ Tconv cells is essentially unknown. Thus, the first aim of this
project will investigate the functional mechanisms by which KLRG1+ Tconv cells modify the TME. We will test
the hypothesis that KLRG1+ Tconv cells are immunosuppressive through adoptive transfer experiments,
secretome, transcriptome, and epigenetic profiling, and genetic depletion to establish the sufficiency and
necessity of KLRG1 on Tconv cells to enhance tumor progression and immune escape. In the second aim, we
will develop KLRG1-specific depleting monoclonal antibodies (mAbs) using glycoengineering strategies to
compare depleting versus blocking immunotherapy in combination with standard anti-PD1 immunotherapy. We
will also utilize a novel bispecific mAb to specifically deplete KLRG1-expressing CD4+ T cells and perform high
parameter spectral flow cytometry to assess compositional shifts of tumor-infiltrating immune populations
resulting from our novel immunotherapeutic strategy. Altogether, the proposed studies offer a hypothesis-driven
approach to elucidate the functional mechanisms of KLRG1 on Tconv cells in the TME, while developing a novel
therapeutic to deplete KLRG1-expressing CD4+ T cells as a novel cancer immunotherapy strategy.

Public health relevance
PROJECT NARRATIVE CD4+ T cells shape the tumor microenvironment to promote antitumor or pro-tumor immunity. Our data suggests a novel, mechanistic link between KLRG1+ FoxP3- CD4+ T cells (Tconv) and both tumor progression and immunotherapy response, yet little is known regarding the functional characteristics of this tumor-infiltrating cell subset. The goal of this proposal is to fill this gap in knowledge by elucidating the functional, transcriptional, and epigenetic characteristics of KLRG1+ CD4+ Tconv in cancer and determine whether novel strategies to deplete KLRG1+ CD4+ T cells can augment antitumor immunity and enhance response to immunotherapy.